Population monitoring of stress markers in underserved communities

PROJECT SUMMARY/ABSTRACT
Daily stresses, as well as social, emotional, and financial challenges, can activate physiological stress. Current
public health monitoring systems cannot quantify community stress levels for millions of low-resource and
underserved communities. By identifying communities experiencing high levels of stress using wastewater-
based epidemiology, public health professionals can allocate resources to communities in need. Additionally,
proactively (rather than retrospectively) identifying stress crises can help alleviate the long-term consequences
of stress such as chronic heart diseases as well as neurological and life-threatening diseases and fatalities.
Wastewater monitoring is a proven strategy to identify areas needing intervention instead of relying on
population surveys or emergency-room, hospital/clinics data statistics. However, current wastewater analysis
requires costly laboratory-based tests that involve labor-intensive sample collection, transportation, and
analysis, resulting in long (days) turnaround times. Giner proposes to develop a compact, portable, label-free
Graphene Field Effect Transistor (G-FET) sensor utilizing high-specificity aptamers for rapid, accurate, cost-
effective, and multiplexed monitoring of well-established stress biomarkers in wastewater samples. Since the
sensor generates rapid results compared to incumbent methods which rely on batch sampling of wastewater
streams followed by expensive, time-consuming analysis, this technology will provide actionable real-time data
at a fraction of the cost of incumbent methods, encouraging widespread use.
The overall goal of the program is to demonstrate a test methodology and a field-ready prototype for
simultaneous detection of multiple stress biomarkers in wastewater at pg/mL levels. To support the proof of
concept and alleviate risk, Giner has successfully detected peptide biomarkers in wastewater solutions
including one of the target stress markers, Neuropeptide Y (NPY). We will add two additional stress
biomarkers, Cortisol and Cortisone, as well as a population marker Paraxanthine in Phase I. Multiple samples
from various wastewater sites will be analyzed with Giner’s sensor and the results will be cross-validated in
house using the gold standard HPLC-MS/MS method. Giner will achieve this by using its prior expertise in
biosensors and wastewater testing and in close collaboration with an interdisciplinary team of scientists, social
scientists, and public health epidemiologists. Once developed, the technology will also be suitable for the
detection of any additional target wastewater biomarkers for which an aptamer can be prepared.

Public health relevance
PROJECT NARRATIVE Giner proposes to develop a compact and portable field instrument for rapid, accurate, and low-cost monitoring of stress biomarkers in wastewater. Given the growing stress-related health disparities in low- resource communities and increased risk of heart disease events associated with intense emotional and physical stress, this technology could provide crucial information to implement interventions to communities with the highest stress levels. By identifying communities experiencing high levels of stress using wastewater, public health professionals and clinicians can target resources to communities in need. In addition, this technology could be deployed at numerous wastewater collection sites to give neighborhood level actionable real-time data at fraction of the cost of incumbent methods.